Investigating of the Mechanisms of Action of CFTR Correctors in RescuingDelta F508-CFTR

ABSTRACT
Cystic fibrosis (CF) is a life-shortening inherited disease caused by the loss or dysfunction of the CF
transmembrane conductance regulator (CFTR) channel activity resulting from mutations. Clinically, chronic lung
disease is the main cause of morbidity and mortality for CF patients. Among the 2000+ disease-causing
mutations, ΔF508 is the most common mutation and associates with a severe form of CF disease. The ideal
therapy for CF associated with ΔF508 requires increasing the quantity of ΔF508-CFTR protein at the plasma
membrane, potentiating the impaired channel gating properties, and improving its stability. This notion was
supported by the approval of two CFTR modulating drugs, Orkambi® (VX-809 + VX-770) and Symdeko® (VX-
661 + VX-770), to treat CF patients homozygous for ΔF508, and by trials with triple combinations (VX-445 + VX-
661 + VX-770; VX-659 + VX-661 + VX-770). It is to be noted that the clinical benefits of approved drugs are
modest and the mechanisms of action of these CFTR correctors are poorly understood. In this grant, we plan to
study the mechanisms of how CFTR correctors promote the maturation of ΔF508-CFTR and stabilize the mutant
protein at the plasma membrane. We will focus on VX- CFTR correctors (VX-661, VX-809, VX-445, and VX-659)
and study the subject from the perspective of CFTR-containing macromolecular complexes. The hypotheses to
be tested are: (i) CFTR correctors (e.g., VX- CFTR correctors) bind directly to ΔF508-CFTR to exert their rescue
effects. A high-affinity binding will produce a better rescue outcome. (ii) The instability of ΔF508-CFTR (with a
short half-life) at the plasma membrane is, at least in part, due to its reduced ability to interact with binding
partners and consequently cannot form a stable macromolecular complex, which leads to its rapid internalization
and targeted for degradation. (iii) CFTR correctors not only help fold ΔF508-CFTR in the ER to promote its
maturation, but also stabilize the mutant protein at the plasma membrane by enhancing its interaction with
binding partners and facilitating the formation of a stable macromolecular complex. And (iv) by isolating the
corrector-associated- and ΔF508-CFTR-containing complexes under different conditions and using proteomics,
we can identify effectors and pathways important in the rescuing process. Click chemistry and photo-affinity
labeling will be used to investigate the interactions and macromolecular complexes formation in various CF
model systems. This study will help us (i) better understand the mechanisms of action of CFTR correctors, (ii)
identify novel targets in ΔF508-CFTR-containing complexes, (iii) develop more potent drugs to combat CF, and
(iv) understand the molecular basis of other human diseases resulting from insufficiently folded and processed
proteins (e.g., P-glycoprotein) and find ways to treat these diseases.

Public health relevance
PROJECT NARRATIVE We propose to study the mechanisms of how CFTR correctors (VX-661, VX-809, and analogs) interact with ΔF508-CFTR to improve the maturation and function of the mutant protein at the cell surface. We will study the subject from the perspective of CFTR-containing macromolecular complexes and employ click chemistry and photo-affinity labeling approaches. The study will help us better understand the mechanisms of action of CFTR correctors, expand our knowledge of CFTR-containing macromolecular complexes, and help identify novel therapeutic targets and develop more potent drugs for cystic fibrosis therapy.